Establishment of a Public-Private Partnership (PPP) to Support Therapy Selection and Testing within RECOVER-TLC

RECOVER-TLC
Abstract for FNIH OT Proposal
Establishment of a Public Private Partnership (PPP) to Support RECOVER-TLC
September 18, 2024
The NIH will collaborate with the FNIH to create a long COVID-19 public-private partnership (PPP) to
accelerate the development of therapeutics, consistent with the FNIH’s own mission and the
Congressional statute by which the FNIH was established to support the NIH in its mission and to
advance collaboration with biomedical researchers from universities, industry, nonprofit organizations,
and other federal agencies, including the US Food and Drug Administration (FDA). The overarching goal
of the FNIH in this new PPP is to support the NIH in designing and implementing a strategic and
coordinated cross-sector approach to address the current long COVID challenges and lack of effective
therapies. This PPP is now known as RECOVER-TLC, the NIH Researching COVID to Enhance Recovery-
Treating Long COVID (RECOVER-TLC).